Program for Resistance, Immunology, Surveillance & Modeling of Malaria in Uganda (PRISM) Renewal

Summary/Abstract
Malaria remains one of the most important global health challenges, with an estimated 215 million cases and
438 thousand deaths each year. Malaria disproportionately affects sub-Saharan Africa, where 88% of cases
and 90% of deaths occur. There has recently been a dramatic increase in the scale up of control interventions
and reduction in the burden of malaria across Africa. However, progress has not been uniform, and in fact has
been slowest in countries with the highest burden, such as Uganda. Our program called “PRISM” has been
based in Uganda, representing the East African region for the International Centers of Excellence for Malaria
Research network. Uganda is emblematic of the challenges faced by high burden countries, where routine
surveillance systems are inadequate to assess trends in the burden of malaria or to monitor the impact of
control interventions. Through PRISM we have implemented a comprehensive malaria surveillance program
including enhanced health facility-based surveillance and detailed longitudinal studies in three regions with
differing transmission intensities. Complementary laboratory-based studies include surveillance for markers of
antimalarial drug and insecticide resistance and serologic measures of malaria exposure. These studies have
greatly improved our understanding of the epidemiology of malaria in Uganda and of the impact of control
interventions. In this renewal application we propose to continue key components of our malaria surveillance
work, but to expand our scope to address more fundamental questions about interactions between the
parasite, mosquito vector, and human host. More intensive longitudinal evaluations will be conducted and
cutting edge molecular studies will be added to better measure exposure to infective bites; more sensitively
identify bloodstream infections; characterize parasite, vector, and human genetic factors that impact on
malaria; and assess impacts of these factors on infectivity and transmission. The program will consist of three
research projects linked together in an integrated manner to maximize scientific discovery. Research project 1
(Resistance project) will use samples collected over time at multiple sites to characterize the evolution of
phenotypic and genotypic markers of drug and insecticide resistance and assess the impacts of these markers
on malaria transmission. Research project 2 (Epidemiology project) will use longitudinal samples from cohorts
to characterize factors that determine whether sporozoite inoculation results in the establishment of blood
stage infection and characterize factors affecting the duration, density, and clinical consequences of blood
stage infections. Research project 3 (Transmission project) will use cohort samples to determine factors
associated with gametocyte production and development, evaluate infectivity of the human host to mosquito
vectors, and characterize the human infectious reservoir. These highly interrelated projects will be conducted
in settings with varied malaria epidemiology and differing population level control intervention to provide critical
information needed to optimize strategies for the control and ultimate elimination of malaria in Uganda.

Public health relevance
Project Narrative Recent increases in funding and resources have provided Africa with the opportunity to greatly reduce the burden of malaria. However, gaps in knowledge remain as to the optimal approaches to malaria control in different epidemiological setting. The central theme of this proposal will be to improve our understanding of factors that influence infection, disease, and transmission in Uganda in the context of different transmission intensities and population level control interventions.